Human and Machine Learning for Customized Control of Assistive Robots

PROJECT SUMMARY
This application will result in a technological platform that re-empowers persons with severe paralysis, by allowing them
to independently control a wide spectrum of robotic actions. Severe paralysis is devastating, and chronic—and reliance
on caregivers is persistent. Assistive machines such as wheelchairs and robotic arms offer a groundbreaking path to
independence: where control over their environment and interactions is returned to the person.
However, to operate complex machines like robotic arms and hands typically poses a difﬁcult learning challenge and
requires complex control signals—and the commercial control interfaces accessible to persons with severe paralysis
(e.g. sip-and-puff, switch-based head arrays) are not adequate. As a result, assistive robotic arms remain largely
inaccessible to those with severe paralysis—arguably the population who would beneﬁt from them most.
The purpose of the proposed study is to provide people with tetraplegia with the means to control robotic arms with
their available body mobility, while concurrently promoting the exercise of available body motions and the maintenance
of physical health. Control interfaces that generate a unique map from a user's body motions to control signals for
a machine offer a customized interaction, however these interfaces have only been used to issue low-dimensional
(2-D) control signals whereas more complex machines require higher-dimensional (e.g. 6-D) signals. We propose
an approach that leverages robotics autonomy and machine learning in order to aid the end-user in learning how to
issue effective higher-dimensional control signals through body motions. Speciﬁcally, initially the human issues a lower-
dimensional control signal and robotics autonomy is used to bridge the gap by taking over whatever is not covered by
the human's control signal. Help from the robotics autonomy is then progressively scaled back, automatically, to cover
fewer and fewer control dimensions as the user becomes more skilled.
The ﬁrst piece to our approach deals with how to extract control signals from the human, using the body-machine
interface. The development and optimization of decoding procedures for controlling a robotic arm using residual body
motions will be addressed under Speciﬁc Aim 1. The second piece to our approach deals with how to interpret control
signals from a human within a paradigm that shares control between the human and robotics autonomy. To identify
which shared-control formulations most effectively utilize the human's control signals will be the topic of Speciﬁc Aim 2.
The ﬁnal piece to our approach deals with how to adapt the shared-control paradigm so that more control is transferred
to the human over time. This adaptation is necessary for the human's learning process, since the goal in the end is for
the human to be able to fully control the robotic arm him/herself, and will be assessed under Speciﬁc Aim 3.
At the completion of this project, tetraplegic end-users will be able to operate a robotic arm using their residual body
motions, through an interface that both promotes the use of residual body motions (and thus also recovery of motor
skill) and adapts with the human as their abilities change over time. By leveraging adaptive robotics autonomy, our
application moreover provides a safe mechanism to facilitate learning how to operate the robotic platform.

Public health relevance
Frequently the more severe a person's motor impairment, the less able they are to operate the very assistive machines, like powered wheelchairs and robotic arms, which might enhance their quality of life. The purpose of the proposed study is to provide people with tetraplegia with the means, through non-invasive technologies, to control robotic arms with their available body mobility, while concurrently promoting the exercise of available body motions and the maintenance of physical health. We propose and study an approach that leverages robot machine learning and autonomy in order to facilitate human motor learning of how to operate a robotic arm using a customized interface, in order to make powered assisted manipulation more accessible to people with severe paralysis. 1